Administrative Core

ABSTRACT - ADMINISTRATIVE CORE
The EaRTH Center Administrative Core will provide leadership, infrastructure, administrative support, advice
and oversight to coordinate all EaRTH Center operations in relationship to the needs of the EaRTH Center
members. It also will provide the interface to UCSF, other NIEHS Core Centers, and our target audience of
graduate-level (nursing and doctoral level seeking, residents, and fellows) and practicing healthcare
professionals. Through its coordination and integration of all EaRTH programs and services, the Administrative
Core will bring together a community of investigators from interrelated disciplines to enhance and extend the
effectiveness of environmental health research at UCSF and beyond. The EaRTH Center will be led by an
Executive Committee that oversees and advises all EaRTH Core and Program activities. The Executive
Committee will be the central decision-making body of the EaRTH Center and will be composed of the Center
Director (also representing Administrative Core), Deputy Director (also representing Pilot Project Program),
Bioassay Core Co-Directors, Integrated Health Sciences Core Co-Directors, and Community Engagement Core
(CEC) Director. In addition to serving an administrative role, members of the Executive Committee will serve as
liaisons of the EaRTH Research Programs, therefore providing integration of the EaRTH scientific programs
within the Executive Committee. Governance will be facilitated by Administrative Core staff. An Award
Administrator will help the Cores and Programs set and monitor their budgets. An Administrative Program
Coordinator will work with the Executive Committee to organize and coordinate all aspects of the Administrative
Core including: all meetings of the components of the EaRTH Center, including the External and Internal Advisory
Committees and CEC Science Advisory Board; the Enrichment Program; external review and Executive
Committee's evaluations of the Cores and programs; communication of findings: and maintain the Center
external and internal website; and member engagement. An Administrative Director of Cores will ensure the
integrated operation of the Cores with the EaRTH Center membership and with the numerous support structures
for shared facilities at UCSF via the Office of Research in the Chancellor's Office. This administrative structure
ensures that the EaRTH Center provides effective support and ensures the effectiveness and success of
environmental health research at UCSF.